HEPATIC EXCRETORY FUNCTION IN BILIARY ATRESIA

The biliary output is totally diverted during surgery for biliary atresia, enabling assessment of excretory function. This protocol utilizes gastrointestinal hormones to stimulate bile flow in acute studies and provides a model to test other agents that might be important diagnostically during low flow periods.